Molecular Targeting of the Cerebrovasculature During Prenatal Alcohol Exposure

PROJECT SUMMARY
Fetal alcohol spectrum disorders (FASD) constitute an array of neurocognitive and behavioral deficits exhibited
by individuals who experience some disability as a result of prenatal alcohol exposure (PAE). In the United
States, the incidence of FASD is estimated to be 20-50/1,000 children. With no curative treatments available, it
is of paramount importance to consider fresh perspectives and improve our understanding of factors driving
FASD-associated deficits. Much research has focused on neuronal-specific defects in the central nervous
system with less attention given to the vascular compartment and in particular to endothelial cell-specific defects
mediated by PAE. Considering the intimate relationship between the developing neuronal and vascular networks
during embryogenesis, it is likely that abnormal vascular development contributes to PAE-associated brain
pathology. Using an established mouse model of moderate PAE, we found that microRNA (miR)-150-5p was
significantly increased in the PAE embryonic cortices and in brain microvascular endothelial cells (BMVECs)
isolated from those cortices compared to controls. miR-150-5p is a negative regulator of angiogenesis and the
blood brain barrier (BBB), and its targets include endothelial-specific transcription factors and matrix
metalloproteinases as well as adherens and tight junction proteins, which were significantly reduced in the same
tissues. Additionally, we found that the vasculature of PAE embryonic cortices displayed significant alterations
including reductions in vessel area and volume, the mean diameter of blood vessels, and BBB integrity. Inhibition
of miR-150-5p or overexpression of its targets restored angiogenesis and decreased permeability of BMVECs
exposed to alcohol. Our long-term goals are to discover novel targets and develop strategies that may be useful
for reversing or alleviating the adverse consequences of PAE. The overall objective of this proposal is to identify
molecular mechanisms and regulators of miR-150-5p that lead to endothelial cell and vascular dysfunction, which
could be harnessed as potential therapeutic targets for improving PAE-mediated effects. Our specific aims are
to first investigate the mechanisms by which miR-150-5p levels are enhanced in BMVECs, examining its
transcriptional and post-transcriptional regulation. We will then evaluate the effect of miR-150-5p on the
molecular and cellular properties of BMVECs and the neurovascular unit (NVU) following PAE, preserving
physiological context and spatial information. Finally, we will examine whether the miR-150-5p-mediated
deviations in vascular morphology and function persist into postnatal life following PAE, using tissue clearing
combined with fluorescence microscopy of the cortical vasculature as well as functional studies of ex vivo
cerebral vessels. This work will uncover novel molecular mechanisms that contribute to vascular defects in PAE
and will provide insight into RNA-based strategies that could be developed for improving PAE-mediated effects.

Public health relevance
PROJECT NARRATIVE A distressingly high number of children in the United States, approximately 2-5%, live with fetal alcohol spectrum disorders, the result of damage to the developing fetus from prenatal alcohol exposure (PAE). Because there are currently no known treatments that can reverse PAE-mediated damage, it is essential that we understand its molecular underpinnings and investigate novel avenues of research such as those defining the role of vascular defects in the developing brain during PAE. This study will uncover novel molecular mechanisms that drive abnormal vascular development in the brain during PAE and reveal potential therapeutic targets for FASD patients.